Determining the role of T cell effector functions in Alopecia Areata

Alopecia areata (AA) is a common autoimmune disease in which the hair follicle is the target of attack
and results clinically in hair loss. The lifetime risk of developing AA is approximately 2%, translating to over 6
million people in the United States developing the disease at some point in their lives. Although often being
dismissed as a cosmetic concern, AA can have a substantive psychosocial impact and can significantly affect
the quality of life of affected individuals, especially among those with the more severe forms. The population
that suffers from this disfiguring disease with significant psychosocial ramifications represents a significant unmet
medical need. In addition, autoimmune diseases in general are rising in prevalence, and at least one study of
veterans have shown an increased risk of autoimmune disease in those veterans suffering from post-traumatic
stress disorder. The common cause hypothesis of autoimmunity, supported by the association of specific genes
to a range of autoimmune diseases, signifies that advances in one autoimmune disease may be applicable to
others. Numerous factors make AA an attractive area of study in this regard: high prevalence, the existence of
an animal model with high fidelity to human disease, and the ease and convenience with which the target end-
organ may be assessed and sampled.
Despite its high prevalence, AA has not been as heavily studied relative to other cutaneous autoimmune
diseases, and there are no treatments approved by the US FDA that list AA as an indication. Despite new interest
and data into the immune mechanisms regulating the development of AA, our understanding of the pathogenic
immune cell types and regulatory circuits that drive this disease significantly lags that of other autoimmune
diseases. Although prior work by us and others have established a critical role for CD4 and CD8 T cells, it is not
known what these cell types are doing to lead to autoimmune attack of the hair follicle. Dissecting which effector
functions of CD4 T cells and CD8 T cells are necessary for AA pathogenesis will focus our understanding of
disease pathogenesis, which can bring us closer to targeted and specific treatments.
AA is characterized histologically by a peribulbar immune infiltrate mostly comprised of T cells, with
CD4 T cells being the most numerous cell type followed by CD8 T cells. We are interested in investigating the
role of pathogenic CD4 and CD8 T cells in the context of the C3H/HeJ murine model of AA, which can either
develop disease spontaneously or develop disease in response to various methods of induction. The goal of
this proposal is to address these critical knowledge gaps and provide mechanistic insight into the role of CD4
and CD8 T cells in the pathogenesis of AA. We will achieve our goal by pursuing two specific Aims. In
Specific Aim 1, we will dissect the impact of CD4 T cell production of interferon gamma on the hair follicle and
AA development. Furthermore, our proposed studies will help define the target of CD4 T cell effector functions
in our in vivo model. In Specific Aim 2, we will determine which effector mechanisms are required by CD8 T
cells for AA development. We expect our studies to identify the pathogenic effector functions used by T cells to
induce disease in AA. Results of this work will inform the development of novel treatment strategies for AA.

Public health relevance
Autoimmune diseases are rising in prevalence. Studies have shown that veterans, especially those suffering from post-traumatic stress disorder, are at an increased risk. The common cause hypothesis of autoimmunity posits that similar mechanisms are responsible for groups of autoimmune diseases, supported by common sets of genes associated with clusters of autoimmune diseases. Advances in one particular autoimmune disease may therefore be applicable to others. The submitted proposal examines pathogenic mechanisms in alopecia areata (AA), in which the hair follicle is the subject of immune attack. In line with the common cause hypothesis, AA is associated with an increased risk of autoimmune thyroiditis and diabetes, among other autoimmune diseases. AA is a highly prevalent autoimmune disease with a lifetime risk of 1 in 50, according to US-based studies. We therefore submit that results achieved in our current proposal are expected to benefit large numbers of US citizens and of particular relevance for veteran and combat veteran populations.